Engineered imaging nanoparticles for real-time detection of cancer in the tumor b

DESCRIPTION (provided by applicant): The overall goal of this application is to evaluate new imaging agents for (1) real-time detection of residual cancer in the tumor bed during surgery in primary colon and lung cancers in mice to eliminate or significantly reduce the need for repeat surgeries and local recurrence, and (2) guiding resection surgeries in canine patients with naturally occurring cancer. In a pilot study, we will also test our imaging technology to improve the detection of lesions during routine colonoscopy examination. Failure to remove cancer cells during surgery is a leading risk factor for local tumor recurrence and subsequent reoperation. Rates of secondary surgeries because of positive margins range between 10-50% depending on cancer type, grade and anatomical site. For colon cancer screening, many small lesions go undetected that are only found after progressing into malignant carcinomas. Furthermore, even for larger carcinomas, colonoscopy using white light will not identify these 22% of the time. Thus, a technology that can assess whether tumor cells have been adequately removed during surgery or can identify colon lesions with higher efficiency will have a major impact on cancer therapy worldwide as more than two million people undergo cancer surgery every year. During the SBIR Phase I work, Lumicell developed several imaging agents by using our novel mathematical model to predict their performance across species. The goal was to develop high-performance, lower cost imaging agents to satisfy the needs for colon cancer screening and eventually skin cancer surgeries. These imaging agents are based upon the design of our lead candidate for sarcoma and breast cancer indications, LUM015, which has been approved by the FDA to start first-in-human clinical trials with our clinical collaborators at Duke University Medical Center. Based upon modifications to LUM015, the new imaging agents cost about 66% less to manufacture with improved yields. After testing them in our baseline mouse model for breast cancer, these new agents proved equal or better performance than LUM015. A lower cost imaging agent is mandatory for entry into several of our new target markets and will be an additional offering for the other markets. For Phase II, we propose in Aims 1 and 2 to evaluate the performance of these imaging agents in state-of-the-art genetically engineered mouse models for lung cancer and colon cancer with our collaborators at Duke University and Massachusetts General Hospital. In Aim 3, we will move forward with the selected lead candidate (based upon results from Aims 1 and 2) into a veterinary clinical trial conducted at Duke/Veterinary Specialty Hospital of the Carolinas and Tufts University Cummings School of Veterinary Medicine. Canine patients suffering from any type of cancer will be recruited to evaluate the performance of the lead candidate in naturally occurring cancers. Aim 4 is focused on reaching the endpoint of this proposal: submit an IND to support a Phase I clinical trial for colon and lung cancer surgeries and colon cancer screening using our new lead candidate.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed project aims to address the unmet clinical need for intraoperative assessment of residual cancer cells in the tumor bed after tumor resection in colon and lung cancer patients, and to improve the efficacy of detecting small lesions during routine colonoscopy examinations. Lumicell has developed new imaging agents to address these needs that also reduce the cost by 66% over our original imaging agent. Their performance will be evaluated in mouse models for lung and colon cancer, and in naturally occurring cancers in canine patients before translating the technology for human use. A lower cost imaging agent is mandatory for entry into several of our new target markets and will be an additional offering for the other markets. This technology has the potential to save lives, prevent secondary surgeries, minimize patient discomfort and surgical risks, and provide substantial savings in healthcare costs. __SpecificAimsTextDelimiter__ Specific Aims The overall goal of this project is to complete the development of new Lumicell imaging agents for guiding colon and lung cancer surgery and for intraoperative imaging for canine patients with cancer. The existing Lumicell imaging agent (LUM015) is in clinical trials for breast cancer and sarcoma. Going forward, the motivation is to develop less expensive, more scalable and broader imaging agents that can be used for other surgeries such as colon and lung cancer resections, and are mandatory for entry in the very large markets of colon cancer screening and dermatologic surgeries for skin cancer. During Phase I SBIR work, Lumicell developed five new imaging agents that were shown to differentially label tumors in a breast cancer mouse model with tumor-to-background ratios > 5:1 and inherent1 sensitivities and specificities > 90%. There is mounting evidence from our own work and that from our collaborators that these types of imaging agents will work well in colon and lung cancers. The lead candidate chosen because of performance and low manufacturing cost is LUM033, the fragment containing the dye and the pharmacokinetic modifier of LUM015. We expect that LUM033 will require minimal additional toxicity studies for an IND submission as it was a component of LUM015, which has undergone toxicity testing in rats. For the Phase II program, we will evaluate the performance of LUM033 (and the alternate lower cost imaging agent LUM032) in mouse models for colon and lung cancer and in canine patients with cancer as part of our current veterinary clinical trial. We will use these data along with any toxicology studies required by the FDA to submit an IND application to support human clinical trials. Specific Aim 1: Evaluate the performance of LUM033 and the alternate LUM032 in a mouse model for colon cancer. Our collaborators at Massachusetts General Hospital (Dr. Umar Mahmood) will use LUM033 and LUM032 to evaluate their performance in colon cancer resection and colon cancer screening in mice. For these experiments we will use a genetically engineered mouse model that produces locally restricted tumors that, similar to human ones, progress into adenocarcinomas and metastases. Cathepsin activatable imaging agents have been shown to effectively label tumors from this model. Specific Aim 2: Evaluate the performance of LUM033 and the alternate LUM032 in a mouse model for lung cancer surgeries. Our collaborators at Duke University Medical Center (Dr. Brian Brigman and Dr. David Kirsch) will evaluate LUM033 and LUM032 in a genetically engineered mouse model for lung cancer. This mouse model has proven to generate tumors that are labeled with cathepsin activatable imaging agents similar to ours. Mice will be injected with our imaging agents and will undergo tumor resection surgeries guided with the LUM imaging device. If LUM032 and LUM033 underperform in the lung cancer mouse model, then we will proceed with LUM015 for the lung cancer indication using the currently approved IND for LUM015. Specific Aim 3: Evaluate the performance of LUM033 in canine patients with naturally occurring cancers. We will continue our current clinical trial in dogs using LUM033 (or LUM032 if it outperforms LUM033) at the Veterinary Specialty Hospital of the Carolinas (Dr. Will Eward) and at Tufts University Cummings School of Veterinary Medicine (Dr. John Berg). Surgeries will be guided with Lumicell's handheld imaging device to obtain negative margins and biopsies from different imaged tissue types will be collected for histological analysis for the presence of cancer. The metrics for evaluating performance in specific aims 1-3 are tumor-to-background ratio, variance of signal distribution, sensitivity and specificity when compared to the presence of cancer by histopathology. Specific Aim 4: Prepare an IND application to support Phase I clinical studies with the lead candidate imaging agent. We anticipate the canine trial, along with the data from mice, will meet most if not all of the toxicology requirements from the FDA since LUM033 was a part of our comprehensive toxicity studies in rats. In addition, this trial will allow us to enter the veterinary market immediately upon completion. We will conduct a pre-IND with the FDA and complete any remaining toxicity studies as we have already done with LUM015 Milestones: (1) Evaluate the sensitivity and specificity of the imaging agents in mouse models of colon cancer screening and lung cancer surgeries. (2) Validate the performance of LUM033 in naturally occurring cancer in a veterinary clinical trial. (3) Submit an IND application for a Phase I clinical trials in humans using LUM033. 1 "Inherent" sensitivity and selectivity is a calculation based upon histograms from tumor and normal tissue in an animal and used as our metric to compare the performance of the imaging agents. It is a predictor of clinical performance but not an actual surgical-pathology score.